Cellular and Biochemical Pathways of Adipose Metabolism and Thermogenesis

PROJECT SUMMARY/ABSTRACT
There is a great deal of interest in adipose biology, particularly in light of the world-wide epidemic in obesity and
metabolic diseases, including type 2 diabetes, cardiovascular disease and cancer. While adipose tissues are
best known as the major storage site for calories, certain fat tissues play a critical role in adaptive
thermogenesis, the process whereby chemical energy is dissipated in the form of heat in response to external
stimuli. Thermogenic adipose tissues, brown and beige, defend the body against hypothermia, obesity and
other metabolic disorders. Critical unmet needs include understanding the detailed molecular pathways by
which chemical energy is converted into heat and the discovery of human therapeutics that might increase
amounts and function of thermogenic fat. Four years ago, we described a previously unknown thermogenic
pathway in brown and beige fat that plays a major role in both energy expenditure and suppression of obesity in
animal models. Disruptions of this futile creatine cycle causes levels of obesity not observed with ablations of
any previously described thermogenic mechanisms, including UCP1; in response to these observations, I am
focusing this grant entirely on further biochemical and physiological studies of this futile creatine pathway. One
Aim will focus on the role of the creatine transporter (CrT) in fat tissues, where preliminary data with adipo-CrT
KO mice shows that this exogenous pathway for creatine accumulation contributes significantly to whole body
energy homeostasis. The physiological role of the CrT specifically in fat will be analyzed with metabolic cages to
study mutant mice under several different physiological perturbations. This mutation will also be combined with
our previous genetic model (adipo-GATM-KO), which is unable to synthesize creatine de novo, to create an
animal model totally lacking adipose accumulation of creatine. A related Aim will be to study regulation of the
CrT mRNA and protein; preliminary data shows mRNA to be down-regulated in fat cells from obese human
subjects. Importantly, we will also use metabolomic studies (LC/MS) to follow the fate of phosphocreatine (CrP),
as it is processed/hydrolyzed in mitochondria from thermogenic fat cells. Our last Aim will focus on a major
unanswered biochemical question: exactly how is the high energy phosphate on CrP dissipated as part of this
futile cycle. In this regard, we have exciting preliminary data using 31P NMR: mitochondrial preparations from
thermogenic fat contain an activity that can hydrolyze CrP directly. We have purified this activity and have
identified it as TNAP, an alkaline phosphatase. While not annotated as a mitochondrial protein, we find a
substantial portion of this protein in the mitochondrial associated membrane (MAM) fraction. We will perform
genetic and pharmacological manipulations of TNAP to determine its role in thermogenesis and the futile
creatine cycle. We will also use protein Mass Spectrometry to determine how this protein may be modified to
achieve its association with mitochondria. Together, these studies will advance basic knowledge of adaptive
thermogenesis and provide potential new avenues to human therapeutics in metabolic diseases.

Public health relevance
PROJECT NARRATIVE Obesity arises from an imbalance between energy input and energy expenditure; increases in energy expenditure can reduce obesity and its metabolic sequelae. Here we propose advanced experiments related to thermogenesis in adipose tissues. We will study the basic biochemical pathways of energy expenditure through futile creatine cycling and we will also study the effects of genetic perturbations inn this pathway.